Adaptive Cerebellar Processing at Cellular Resolution in Flexible Behavior

PROJECT SUMMARY/ABSTRACT
The cerebellum integrates sensory, motor, and internal information to rapidly guide and fine-tune action. This
process has been investigated most extensively for movement control, but the cerebellum is also involved in
the updating of internal states such as reward and working memory. Previous work from this laboratory shows
that the cerebellar region crus I is required for evidence accumulation and decision-making. These findings,
along with preliminary data, led to the hypothesis that cerebellar processing of sensory and internal information
evolves over the course of learning to exert moment-to-moment predictive influence and shape flexible
behavior. The proposed experiments will determine, with quantitative rigor, how cognitive regions of the
cerebellum contribute to neural coding, predictive learning, and forebrain target activity. Past studies of
cerebellar contributions to cognition have been hampered by the coarseness with which neuronal activity could
be monitored and perturbed, pathways traced, and behavior measured. This proposal will overcome these
limitations by using advanced tools, including two-photon calcium imaging, whole-brain transsynaptic viral
tracing, high-density silicon probe recording, and optogenetic perturbation. Aim 1 will determine how predictive
information in cerebellar activity influences working memory. In an evidence-accumulation decision task that
distinguishes neural activity related to evidence accumulation, information retention, and decisions, preliminary
data show that optogenetic inactivation of crus I removes the dependence of decisions on previous evidence,
indicating a necessary role in evidence integration. This aim will examine the main cerebellar pathway with
optogenetics, two-photon imaging, and many-electrode recording to probe learned cerebellar contributions to
sensory processing, working memory, decisions, and motor output with subsecond time resolution. Aim 2 will
characterize learning and transfer of working memory-related neural dynamics. This aim will examine how task
representations evolve during learning in Purkinje cells and deep-nuclear neurons to test the idea that intrinsic
cerebellar signals involved in movement preparation provide a foundation for learning neural responses that
accumulate sensory evidence over time. Aim 3 will evaluate how cerebellar areas involved in cognition shape
activity in connected forebrain areas. This aim will use transsynaptic viral tracing to identify pathways from crus
I through midbrain and thalamus to their targets in the neocortex, and then specifically perturb and monitor
these pathways to identify their contribution to task performance. The long-term goal of this project is to build a
quantitative explanatory framework for cerebellar function in complex behavior. The results are expected to
inform computational models that predict and explain the impact of detailed cerebellum-forebrain interactions.
Together, these studies will significantly advance basic neuroscience of the cerebellum and contribute to
understanding of syndromes marked by cerebellar dysfunction, including attention-deficit hyperactivity disorder
and autism spectrum disorder.

Public health relevance
Project Narrative The cerebellum, a brain region implicated in fine-tuning of movements, also influences social interaction and updating of cognitive states such as reward and working memory. Cerebellar injury in humans and other animals leads to pronounced social and cognitive deficits, especially when it occurs early in life. The proposed studies will uncover how neural activity in the cerebellum modulates cognitive task performance in mice and thus contribute to understanding of syndromes marked by cerebellar dysfunction, including attention-deficit hyperactivity disorder, obsessive-compulsive disorder, and autism spectrum disorder.